Characterizing and modeling the genomewide molecular basis of gene-environment interactions

PROJECT SUMMARY/ABSTRACT
Organismal phenotypes in a given environment frequently differ from what might be expected based on
genotypic or environmental data alone. These genotype-specific deviations, or gene-environment interactions
(GxE), can constitute a large portion of phenotypic variation and are important for determining an individual’s
wellbeing in its given environment. An individual adapted to a particular environment can respond appropriately
to typical local stresses and nutrients, but may be maladapted in new or changing environments. GxE also
makes it exceedingly difficult to predict organismal response to the environment: the magnitude and direction
of GxE effects depend on the loci, alleles, traits, and environments involved. This complicates extrapolation of
genomic prediction models into new populations or environments. Although it is well established that GxE is a
major contributor to phenotypic variation, much less is known about the molecular mechanisms determining
individuals’ differential response to environments. This is particularly true in complex, real world environments
that are impossible to reproduce in laboratory experiments. Genomewide, allelic variation for gene expression
cumulatively influences GxE of organism-level phenotypes, but the complex networks and patterns of gene
regulation driving GxE are not well understood. Over the coming five years, this project will generate new
datasets and analyze existing datasets to begin understanding and modeling the genomewide patterns of
gene expression that cumulatively determine GxE in real world environments. In Aim 1, tissue samples
from multi-environmental experiments will be used to evaluate the landscape of gene expression among
genetically diverse individuals grown in a variety of environments. Specifically, we will investigate how changes
to cis-regulatory sequences (e.g. transcription factor binding motifs) contribute to GxE for gene expression.
Simultaneously, we will identify genes that show GxE for expression levels and model how they contribute to
GxE for organism-level phenotypes. In Aim 2, we will use existing datasets independent yet complementary to
those generated in Aim 1 to test whether GxE in organism-level phenotypes can be predicted directly from
sequence variation. Together the multi-scale projects in this study range from the sequence level to the entire
organism. By studying GxE at multiple scales and with a variety of different data types, this study will
strengthen our understanding of how allelic sequence variation changes gene regulatory networks and drives
local adaptation. These findings are important for understanding how organisms adapt to new environments
and for better predicting organismal response to the environment.

Public health relevance
PROJECT NARRATIVE Gene-environment interactions (GxE) are widespread and contribute to phenotypic variation, environmental response, and adaptation, but we do not understand how genetic differences between individuals cause GxE. My research will use genome sequence, gene expression, and phenotypic data from genetically diverse individuals and a range of real-world environments to understand how GxE occurs at different scales. This research will help us to predict phenotypes across broader ranges of environmental conditions and contribute to a better understanding of how organisms adapt to new or changing environments.